Tissue Microarray and Imaging

The DF/HCC Tissue Microarray and Imaging Core is dedicated to the construction, imaging and analysis of high-quality tissue microarrays for cancer research, as well as high-throughput isolation of DNA and RNA from formalin-fixed, paraffin-embedded tissues. The Core is currentiy the only centralized facility within the DF/HCC community that is capable of constructing large-scale, high-quality tissue microarrays. In summary, tissue microarrays enable large-scale, high-throughput in-situ analysis of gene and protein expression. The facility was first approved through the CCSG mechanism at the time of the 2005 renewal. Director: Sabina Signoretti, MD(BWH) Category: 4.06 (Human Tissue Acquisition & Pathology/Histology) Management: Joint (Cancer Center and Institution)

Public health relevance
The TMI Core facilitates translational research through the discovery and validation of novel potential drug targets. This is accomplished by providing access to this resource, as well as enabling computer-based image analysis and high-throughput nucleic acid extraction.